Thermal-plex: fluidic-free, rapid sequential multiplexed imaging of RNA and protein in brain tissues

Project Summary
Multiplexed imaging of brain cells and tissues can reveal critical details about the abundance and spatial
organization of molecular targets. Sequential imaging methods based on iterative labeling and imaging enables
practical higher multiplexing, but generally require complex fluidic setup with multiple rounds of slow buffer
exchange. We propose to develop the thermal-plex method which removes complex and slow buffer exchange
steps, and provides a fluidic-free, rapid sequential imaging method. Thermal-plex uses simple DNA-probes that
are engineered to sequentially fluoresce when and only when heated to designated temperatures (thermal
channels). Channel switching is fast (<30 seconds), and is achieved with commercially available and affordable
on-scope heating device. In our preliminary work, we have demonstrated 15-plex RNA imaging (5 thermal × 3
fluorescence channels) in fixed cells in less than 4 minutes, without using buffer-exchange or fluidics. In this
proposal, we will further develop and validate thermal-plex for imaging RNA and protein targets in brain tissues.
By removing complex and slow fluidics, thermal-plex increases the ease and speed of practical sequential
multiplexed imaging for brain research.

Public health relevance
Project Narrative The proposed research will result in technology that enables the wash-free, multiplexed imaging of protein and RNA in the brain. The proposed technology will greatly boost the throughput of data acquisition and open up the ability to rapidly map the key building blocks of brain cells. The scalable toolsets we proposed will empower the research community to efficiently interrogate the cell-specific and circuit-specific processes in the brain.